Implications of 12-Lipoxygenase and NOX-1 in beta-Cell dysfunction, a potential target for Diabetes

During this period, the NCATS Early Translation Branch has worked to further advance the selective 12-LOX inhibitors identified previously through ADME characterization. As a branch, ETB has fostered and maintained over 130 active collaborations with both NIH and extramural investigators, facilitating drug discovery efforts across the entire spectrum of human disease. These efforts have led to dozens of high-throughput screens and a number of medicinal chemistry campaigns to further improve on screening hits, providing our collaborators and the general research community with publications and a variety of promising small molecule probes and leads. In addition, ETB has worked to advance a number of informatics initiatives to make better use of existing drug and disease target information and provide the general public with easily accessible resources, further catalyzing the development of new therapies for human disease.